Wnt Signaling Gordon Research Conference and Seminar

We request partial support for the Gordon Research Conference (GRC) and Gordon Research Seminar (GRS)
titled "Wnt signaling: mechanisms, biology & therapy" to be held June 20-27th, 2025 at Bates College (Lewiston,
ME). The GRC portion of the meeting will be chaired by Ken Cadigan (University of Michigan, USA) Madelon
Maurice (UMC Utrecht, Netherlands) with Marian Waterman (University of California, Irvine, USA) and Rami
Hannoush (Versant Ventures) as Vice-Chairs. The GRC include presentations from many prominent scientists,
at varied career stages, active in the field of Wnt biology. The GRS will be held at the same location June 20-
21st, 2025 and will feature talks from graduate students and postdoctoral fellows. The GRS will be led by Drs.
Lucie Wolf (post-doctoral fellow at the University of Toronto) and Pierfrancesco Pagella (Associate Professor,
Linköping University; Dr. Pagella was elected co-chair of the GRS while still a post-doctoral fellow). The major
goal of the conference is to provide a forum for the presentation and discussion of recent advances and new
ideas in all aspects of Wnt biology and molecular biology. The Wnt signaling field is highly active (almost 1800
publications listed in PubMed in 2024 alone) and is required for countless developmental, tissue homeostasis
and physiological functions throughout metazoans. In addition, de-regulation of Wnt signaling is widely
recognized as a critical regulator numerous human disorders, from early developmental abnormalities to age-
related diseases, such as cancer.
Session topics have been selected to highlight active areas of Wnt signaling. Several sessions will focus on the
rich Wnt biology that continues to expand, including development, stem cell biology and cancer. These questions
will be explored in a wide variety of invertebrate organisms (cnidarians, Drosophila and C. elegans) as well as
vertebrate models (frogs, fish and mice). Cell and organoid cultures will also be prominently represented and a
session on therapeutic interventions will touch upon some of the efforts to drug this major pathway. Mechanisms
of Wnt signal transduction, including ligand-receptor interactions, regulation of β-catenin stability and
transcriptional regulation of Wnt targets will be examined at the genetic, biochemical and structural levels. A
section on β-catenin-independent signaling recognizes the importance of the so-called "non-canonical" pathways
by which Wnt regulate cell behavior. Based on past Wnt signaling GRCs, this meeting will attract a diverse array
of junior and senior researchers from North America, Europe and Asia. This gathering will provide information
exchange that is essential for keeping abreast of new developments, as well as provide an excellent entry point
for younger researchers to appreciate the scope of this active field and make important contacts for their career
advancement. We expect the reporting of new discoveries and the establishment of new collaborations that will
continue to push this field forward in a cooperative manner.

Public health relevance
The 2025 Gordon Research Conference and Gorden Research Seminar titled "Wnt signaling: mechanisms, biology & therapy" will advance our understanding of how the highly conserved Wnt signaling pathway influences developmental processes and disease. This meeting will cover a broad spectrum of biological systems, approaches and methodologies and bring together a diverse group of scientists, including structural, cell and developmental biologists, as well as stem cell and cancer researchers.